Interaction between nuclear epigenetic and metabolic pathways in cancer

Abstract
Despite
cancer
impressive strides in conventional small molecule therapeutics and novel cancer immunotherapies,
continues to be a devastating disease. Certain cancers are refractory to available therapies, and
patients' responses show large individual variability. Cancer involves striking dysregulation of epigenetic
pathways, with pharmacological approaches targeting chromatin regulators in the clinic and under
development. There is also profound involvement of metabolic pathways in cancer, including fascinating
nuclear-localized metabolic enzymes. These paradigm-shifting pathways represent an entirely new avenue for
targeted therapies, with the potential to directly and specifically modulate cancer-related gene expression
programs. However, our understanding of epigenetic mechanisms in cancer, especially as they connect
to nuclear metabolic pathways, remains in its infancy. Our history of groundbreaking research revealing
new chromatin biology and uncovering genomics and proteomics of the transcription factor p53, both in its role
as a crucial tumor suppressor and as a ruinous oncogene, underpins our proposed novel directions. In
addition, we have new findings of a chromatin-localized role of a cancer-linked metabolic enzyme directly
“fueling” a histone modifying enzyme. Utilizing this background, in this revised proposal, we propose to
investigate novel epigenetic regulation and its intersection with nuclear metabolism, using a variety of normal
and cancer cell lines, as well as translational mouse models of cancer. We will investigate pivotal
developmental- and disease-relevant DNA regulatory elements, called enhancers, which our published findings
expose as crucial in p53 function, but which remain understudied in both wildtype and mutant p53 function. In
addition, we have recently illuminated a
with
will
speckles
chromatin,
expression.
enzyme
wholly novel and unanticipated mechanism of wildtype p53 associating
membrane-less bodies, called nuclear speckles, to traffic p53's gene targets for enhanced expression; we
dive deeply into the underlying mechanisms for wildtype and oncogenic p53, and explore alterations of
in cancer. Other recent findings implicate a nuclear metabolic-epigenetic axis to coordinate, directly at
metabolic enzyme production of cofactors with chromatin enzyme function to activate gene
We will unravel mechanisms underlying this organization, identify new examples of metabolic
coordination with epigenetic enzymes, and determinewhether the nuclear metabolic-epigenetic axis is
critical to cancer. Crucially, we have developed an inhibitor targeting ACSS2, a nuclear metabolic enzyme,
which presages potential new advancement in therapy. Taken together, our combined focus on roles and
interactions of epigenetics and metabolism related to cancer promises to delineate novel mechanisms
involved in tumor formation. This paradigm-shifting, multidisciplinary work will bridge separate but
related areas of cancer biology and is thus ideal for this broad funding mechanism. Critically, results
from our research will guide much-needed future treatments and significantly benefit patient populations.

Public health relevance
Narrative Despite impressive advancements in treatment, cancer continues to be devastating. Prominent among changes that cause cancer are alterations to metabolic and epigenetic pathways, and there is surprising evidence that these pathways directly communicate to regulate gene expression. Tackling these interconnected pathways for new insights will guide future novel treatments and will benefit patient populations.